Characterization of epigenetic modifications during MHV68 lytic/latent infection

Epigenetic modifications of histones plays a critical role in regulating the life cycle of gammaherpesviruses. An emerging theme in noncoding RNA (ncRNA) biology is a central role for these molecules in regulating epigenetic machinery. However, the role of ncRNAs in gammaherpesvirus infections, and the relationship between viral ncRNAs and epigenetics in the context of gammaherpesviruses, is poorly understood. Murine gammaherpesvirus 68 (MHV68) is genetically and pathogenically related to the human gammaherpesviruses, and infection of mice provides a unique system with which to study the interplay between epigenetics and viral ncRNAs. Previous studies have demonstrated that epigenetic modifications to herpesvirus genomes plays a central role in the regulation of lytic replication and the establishment/maintenance of EBV and KSHV latency. Recent reports have demonstrated that ncRNAs have the capacity to actively regulate epigenetic machinery. Such epi-ncRNAs are also likely to be crucial regulators of epigenetic modifications of histones associated with the viral genome and thus overall viral gene expression. Using MHV68-recombinant viruses lacking various ncRNAs, we have observed altered regulation of key components of the chromatin remodeling machinery, strongly suggesting that MHV68-encoded ncRNAs play an important role in regulation of epigenetically-regulated viral processes. Further defining the nature of this relationship should elucidate the roles for these ncRNAs in chronic gammaherpesvirus infection and pathogenesis.

Public health relevance
Gammaherpesviruses are ubiquitous viruses that establish lifelong chronic infections and are associated with the development of numerous types of cancers. “Epigenetic” modifications to structural proteins associated with gammaherpesvirus genomes are well known to be critical for the establishment of lifelong latent infection. In work described here we will determine whether unique noncoding RNAs expressed by a murine gammaherpesvirus play key roles in regulation of these epigenetic modifications, and whether in so doing they facilitate chronic infection and tumorigenesis.